Identifying the Mechanisms and Localization of Activity-Dependent CaMKII Synthesis

Project Summary
At the Drosophila neuromuscular junction (NMJ), repetitive stimulation has been shown to induce various
forms of protein synthesis-dependent plasticity, including growth of immature “ghost” boutons and potentiation
of miniature excitatory junction potential (mEJP) frequency. There is a concurrent increase in
calcium/calmodulin-dependent protein kinase II (CaMKII) protein abundance, which is required for plasticity.
The molecular mechanisms of this increase in CaMKII are not well understood, and previous studies
examining this effect did not differentiate between the presynaptic and postsynaptic sides of the NMJ. The
Drosophila NMJ has a wide variety of genetic tools to separate the motoneuron and muscle, making it an ideal
model for separating presynaptic and postsynaptic mechanisms. Preliminary data indicate that after spaced
depolarization with a high potassium solution, CaMKII levels increase in both the presynaptic and postsynaptic
sides of the NMJ. Additionally, this increase was blocked by application of cycloheximide, a translation
inhibitor, indicating that CaMKII accumulation is dependent on protein synthesis and is unlikely to be due to
protein translocation or transport. The goal of this research proposal is to identify the molecular mechanisms
and localization of CaMKII synthesis on both sides of the synapse. In the first part of Aim 1, GFP reporter
constructs will be used to determine the sequences in the CaMKII 3’UTR that are required for activity-
dependent translation. In the second part of Aim 1, the trans-acting proteins that bind to the UTR will be
identified using RNA affinity purification. The results from these experiments will elucidate the specific cis- and
trans-acting factors that are required for activity-dependent CaMKII protein synthesis, and determine whether
similar mechanisms act pre- and post-synaptically. In Aim 2, Flp-Frt recombination will be used to delete either
the CaMKII catalytic domain or the 3’UTR and the effect on potentiation of mEJP frequency will be determined.
The excision of the domains will be done exclusively in the presynaptic or postsynaptic compartment, so that
the contribution of either the motoneuron or muscle can be clearly separated. In Aim 3, the subcellular
localization of newly-synthesized CaMKII will be compared to that of pre-existing CaMKII. The function of this
newly-synthesized CaMKII pool is unknown, and this experiment will determine whether the newly-synthesized
CaMKII is targeted to a distinct subcellular nanodomain. Ultimately, this research plan will clarify how
compartment-specific CaMKII synthesis may be contributing to long-term functional changes in the synapse
and may identify new avenues of research into CaMKII-dependent plasticity. While conducting this research,
in-depth training will be provided in a variety of crucial skills, including research design, statistical analysis,
communication skills, super-resolution microscopy, and image analysis.

Public health relevance
Project Narrative Synthesis of new protein is necessary for the long-term adaptations in synaptic structure and function that are required for learning and memory formation. CaMKII, an important neuronal protein, is synthesized after neuronal activity, but it is not well understood how this process is controlled, nor how it is coordinated presynaptically and postsynaptically. This project will build an understanding of these mechanisms and may provide insight into brain disorders linked to CaMKII dysfunction such as intellectual disability and Alzheimer’s disease.